Regulation of the Class IA PI 3-kinase PIK3CB

DESCRIPTION (provided by applicant): The Class I Phosphoinositide 3-kinases (PI3Ks) regulate a wide range of cellular functions, including growth and survival, metabolism, lipid and protein synthesis, and motility. Of the Class I enzymes, only PI3Kβ is regulated both by receptor tyrosine kinases (RTKs) and G-protein coupled receptors (GPCRs), the latter through direct binding of the PI3Kβ catalytic subunit (p110β) to Gβγ subunits. We recently provided the first mechanistic information about GPCR regulation of PI3Kβ, by identifying and mutating the p110β binding site for Gβγ. Surprisingly, many of the cellular activities of PI3Kβ, including its abilityto transform fibroblasts and to support the growth of PTEN-null tumor cells, require its interactions with Gβγ subunits. Moreover, when we replace endogenous p110β with a GPCR-uncoupled mutant in breast tumor cells, the cells show decreased in vitro 3D invasion, decreased tumor growth in an orthotopic model, and decreased metastasis in an in vivo metastasis assay. Notably, disrupting GPCR inputs to PI3Kβ caused a greater decrease in tumor growth than eliminating PI3Kβ lipid kinase activity. These data suggest that GCPR coupling to PI3Kβ plays critical roles in tumor development and metastasis. This coupling could provide an important new drug target for cancer chemotherapy. In addition to Gβγ, p110β also binds the small GTPase Rab5. We identified and mutated the Rab5 binding site in p110β. Cells expressing Rab5-uncoupled p110β show pronounced defects in macropinocytosis, a clathrin-independent endocytic process used by tumor cells to obtain nutrients that support rapid growth. These data suggest that Rab5-PI3Kβ interactions could provide a novel drug target for some tumors. Finally, published studies have shown that the PTEN tumor suppressor forms a complex with p110β in cells, whereas in vitro data shows that PTEN preferentially binds dimers of the p85 regulatory subunit. These data appear to be incompatible, as p85 is not thought to dimerize when bound to p110 catalytic subunits. We have developed novel tools for manipulating the multimeric state of p85, which we can use to define how p85 and p110β interact with PTEN. Specific Aim 1 examines GPCR signaling to PI3Kβ in mouse models of prostate and endometrial cancer, using conditional and whole animal knock-ins of mutant p110β. Aim 2 proposes mechanistic studies on the regulation of macropinocytosis by Rab5-PI3Kβ interactions, and examines the role of Rab5-p110β binding in dendritic cell function and in a K-Ras-driven model of pancreatic cancer. Finally, Aim 3 uses analytical ultracentrifugation, which measures the molecular weight of oligomers independently of shape, to define interactions between PTEN and PI3Ks. Taken together, we have identified novel mutants, made novel biological tools, and devised new experimental strategies, to better define the role of PI3Kβ in cell biology and human disease.

Public health relevance
PUBLIC HEALTH RELEVANCE: PI 3-kinases are intracellular enzymes that play an important role in cell proliferation and survival, and which frequently contain activating mutations in human cancers. Understanding the mechanisms that regulate their activity in normal and malignant cells is critical for the design of novel and specific drugs to target these enzymes in human disease.